A point-of-care device for the determination of homocysteine (Hcy), the Hcy Now

Abstract
This application pertains to the National Center for Advancing Translational Sciences SBIR/STTR Omnibus
Solicitation (preferred). In Vitro Diagnostic Solutions (IVDS) aims to develop a quantitative, home monitoring
point-of-care test for determining total blood homocysteine (tHcy) levels which will significantly improve the
management of Homocystinurias (HCUs). HCUs are inherited metabolic disorders which lead to the
accumulation of plasma Hcy. Classical HCU, the most common disorder, is caused by deficiency in the
enzyme known as cystathionine beta-synthase. Additionally, other HCUs (cobalamin (Cbl) disorders C, D, E, F,
G, J, K, X, and severe MTHFR are also part of the homocystinuria group) can lead to the accumulation of Hcy.
While newborn screening programs in the US test for Classical HCU, not all cases are detected which causes
severe irreversible side effects. Early diagnosis and treatment for HCUs avoids the debilitating and deadly side
effects of HCUs. High levels of Hcy can result in nearsightedness, developmental and cognitive deficits,
seizures, psychiatric disorders, behavior problems, excessive growth of bones, blood clots, coronary artery
disease, myocardial infarction, peripheral vascular disease, strokes, and in severe, untreated cases, death.
Previously published literature estimated the prevalence of HCU at approximately 1 in 100,000 worldwide.
However, a recent study published by the NIH reveals that the actual prevalence of HCU may be 10 times
higher (1 in 10,000), and that HCU is not diagnosed until later in life. Current testing for blood Hcy involves a lab
visit for a blood draw with test results taking days to weeks. Due to the scarcity of labs capable of measuring
Hcy, most patients get tested quarterly or biannually limiting the patient’s ability to effectively manage their Hcy
levels through diet and medication. Wide variations in a patient’s Hcy levels and infrequent testing does not
provide the full scope of how levels are varying over time. There is an urgent, unmet need for simple-to-use,
accurate home monitoring device for tHcy determination to help patients manage their diet and medications.
The Hcy Now is cost-effective, portable, and a simple-to-use device for the home monitoring of blood Hcy
levels. A mobile app displays and stores results of Hcy concentration Mol/L, which can be remotely
disseminated to the care provider to make essential decisions on diet, medications, or if it requires an ER visit.
Execution of this platform will shift the clinical paradigm surrounding HCU patient management. The specific
aims of this proposal are: 1) Finalize Hcy Detection Formulation, 2) Analytical Validation of Membrane
Formulations, 3) Eliminate Hematocrit Bias in the Range of 30% to 52%, 4) Point of Care Mobile Application, 5)
Establish Concordance of Hcy Now to the reference analyzer using patient samples.

Public health relevance
Project Narrative Homocystinurias (HCUs) are a group of inherited metabolic disorders leading to build up of homocysteine (Hcy) and its metabolites in the blood and urine. The Hcy Now proposed herein will be the first remote home monitoring and testing platform for real-time total blood Hcy concentrations. Such a platform will revolutionize the management of HCU patients reducing severe health outcomes and providing personalized disease management.